Lung-specific expression and function of Blimp-1 in T cells impacting allergic asthma

PROJECT SUMMARY
Allergic asthma is a chronic inflammatory disease of the lung that drives a type 2 cytokine response (such as IL-
4, IL-5, and IL-13) predominately produced by activated CD4 T cells of a Th2 phenotype in response to exposure
with environmental allergens. The master transcription factor GATA3 is known to drive Th2 development and
promote type 2 cytokine production, however, the molecular pathways that drive Th2 cells to allergens at both
the initiation and recall stages are not well understood. We have reported that Blimp-1 is an unexpected driver
of allergic asthma that is critical to promote Th2 cell development in the lung and subsequent airway
inflammation. Blimp-1 is a transcriptional repressor that is pleiotropically expressed by effector T cells and can
regulate effector cell responses to constrain T cell-mediated autoimmunity. The purpose of this proposal is to
understand the tissue-specific environmental niche of the lung that promotes Blimp-1 expression to drive Th2
development in the lung and subsequent inflammation in response to allergens. We have shown that the IL-10-
STAT3-Blimp-1 axis is critical for Blimp-1 to promote Th2 cells in response to inhaled allergens. We now
hypothesize that inhalation of allergens creates a lung-specific inflammatory environment to promote Blimp-1
and drive differentiation Th2 cells in both primary and memory responses to allergen leading to cycle of chronic
lung inflammation. We will explore this hypothesis in three aims: (1) Demonstrate that expression of Blimp-1
requires IL-10 from lung-derived migratory cDC2s produced in response to inhaled allergens. (2) Determine if
the kinetics of Blimp-1 expression in T cells underlie its context-dependent function to drive Th2 differentiation
or constrain effector T cells. (3) Demonstrate that allergen-specific memory T cells require Blimp-1 for Th2 driven
recall responses in the lung. Overall, we will determine the role of Blimp-1 in de novo generation of Th2 cells to
drive a type 2 niche and promote persistent inflammation. This study is significant because of its potential to
identify pathways regulating Th2 cells in response to chronic allergens, as well as to elucidate the context-
dependent function of Blimp-1, an important regulator of effector T cell differentiation and function. This work
therefore will demonstrate how tissue-specific and context-dependent immunity must be considered in
therapeutic approaches for diseases associated with tissues such as allergic asthma.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant for human health and disease because allergic asthma is currently on the rise in the United States, therefore there is a need to understand the mechanisms that drive disease in order to identify new targets for the development of therapeutic options. Our proposal has identified Blimp-1 as a novel tissue-specific driver of allergic asthma that is required for the development of allergen-specific Th2 cells known to drive inflammation of the lung and subsequent airway inflammation. Therefore, this research has translational significance for patients with asthma while also elucidating basic mechanisms of the pathogenesis of allergic disease and T cell responses to allergens.